Scripps Center for Ocean and Human Health

DESCRIPTION (provided by applicant) The specific aims of the Administrative Core are to: 1) Provide the administrative infrastructure for the Center, including the initial point of contact and information clearinghouse for all stakeholders, including collaborators, funding agencies, and the community. 2) Facilitate communication and collaboration between the three R0Is and the Analytical Facility Core. 3) Provide a platform for Center activities, including evaluation. 4) Manage all conference and workshop logistics. 5) Maintain the website and engage in community outreach by updating content with Center research and related activities. 6) Facilitate communication and collaboration across the currently funded Centers for Ocean and Human Health and applicable R0Is funded under the companion FOA RFA-ES-11-013. 7) Ensure all NIH reporting requirements are met.

Public health relevance
RELEVANCE (See instructions): We envision that the Center will help define the public health risks of naturally produced HOCs, provide better informed fisheries management and aquaculture practices, assist with quantifying risks associated with seafood consumption, and help to design relevant multiple exposure studies with respect to HOC toxicity.